Optimized protocols for ovarian tissue cryopreservation and novel modRNA-based approaches to improve transplantation outcomes for fertility preservation in chronically diseased girls

Project Summary
With increased diagnostic precision and expanded treatment options, the health and lifespan of children
born with chronic diseases has extended significantly into adulthood, drawing attention to preserving their
quality of life and reproductive options. Unfortunately, the pathology of many chronic conditions can have
negative consequences for the gonad, resulting in infertility and/or premature menopause.
Cryopreservation (and later auto-transplantation) of whole ovarian tissue could provide a means of “safe-
guarding” ovarian reserve from the gonadotoxic effects of disease pathology, and this approach has been
utilized in cancer patients to yield at least 100 live births since early attempts more than a decade ago.
Although this approach is effective, the viability and productivity of cryopreserved ovarian tissue is
drastically undermined by the inflammatory, ischemic environment within the graft during the acute phase
post-transplant.
This proposal leverages the potent bioactivity and straightforward delivery of modified mRNA
(modRNA) as a therapeutic approach to improving the viability and output of ovarian tissue autografts.
Using a xenograft platform developed by our group, we will investigate the potential for modRNA to: 1)
improve viability and output of ovarian tissue transplanted for the purpose of fertility preservation; 2)
maintain a robust pool of ovarian follicles in a quiescent primordial state that will serve as a long-term
reservoir for normalization of endocrine function and oocyte output; and 3) demonstrate the efficacy of this
approach in a highly relevant pre-clinical animal model, rhesus macaque. With these experiments we will
establish a foundation for robust, repeatable and FDA-approvable methods for ovarian tissue
cryopreservation/auto-transplantation in chronically diseased girls that wish to maintain their reproductive
options.

Public health relevance
Project Narrative For young girls affected by cancer and chronic disease, increased diagnostic precision and improved treatments have resulted in significant extension of health and lifespan into reproductive years and beyond, drawing attention to therapeutic strategies that mitigate the adverse effect of disease pathology on fertility in these patients. A method for safe-guarding fertility that has been demonstrated in cancer patients is ovarian tissue cryopreservation in advance of ablative therapy, followed by auto-transplantation upon remission, however, productivity of auto-grafts is severely undermined by negative influences related to re- integration with vasculature at the site of transplant. Using a combination of xenografts of human/macaque and autografts of macaque ovarian tissue, we will investigate the efficacy of modified mRNAs for: 1) improved viability and functional output of auto-transplanted ovarian tissue and and 2) retention of the ovarian reserve in a quiescent state.